New insights into the functional diversity of the hepatic antiviral T cell response during hepacivirus infection in vivo

Inflammatory liver diseases such as chronic hepatitis C virus (HCV) infection can progress to liver fibrosis and
hepatocellular carcinoma (HCC). Hepatic T cell immunity is closely linked to liver diseases since T cells are not
only essential for the clearance of hepatotropic viruses like HCV but may also cause liver injury and contribute
to disease progression. However, the specific role of functionally distinct CD4+ and CD8+ T cell subsets or
innate-like T cells, such as natural killer T (NKT) cells, in mediating an effective antiviral immune response or
regulating liver damage during inflammation are not well understood. Thus, gaining new insights into the
functional biology of hepatic T cell subsets is a prerequisite for the development of HCV vaccine strategies and
immunotherapeutic options for the treatment of progressive liver diseases.
Limited access to human liver tissue and the lack of immune-competent small animal models has impeded
studies of hepatic antiviral immune mechanisms. However, we have recently developed an immune-competent
mouse model of an HCV-related virus, Norway rat hepacivirus (NrHV), which shares significant virological and
immunological similarities with HCV infection in humans. This advance now allows for in-depth mechanistic
studies of anti-hepaciviral immunity in vivo.
Our initial analysis of hepatic lymphocyte subsets during acute, chronic and secondary NrHV infection revealed
a significant induction of a diverse antiviral type 1 T cell response and T cell dependent viral clearance. However,
we also made the unexpected observation that subsets of hepatic CD8+ T cells and NKT cells are polarized
towards type 2 immunity and may contribute to immune-regulation. In this proposal, we will build on these
preliminary data and elucidate the functional properties and potential crosstalk of distinct hepatic type 1 T cells
and type 2 cytokine secreting lymphocyte subsets during NrHV infection. Specifically, we will use high-
dimensional flow cytometry, in vivo functional approaches and/or transcriptome analysis to 1) define the
functional role of different virus-specific effector and memory CD8+ T cell subsets, 2) determine the kinetic and
impact of CD4+ T cells on the generation of virus-specific CD8+ T cells and protective immunity, 3) delineate the
function of type 2 CD8+ and NKT cell subsets and define their impact on liver damage, virus-specific T cells and
other hepatic immune cells during different stages of infection. Finally, we aim to translate our main findings from
the mouse model to human HCV patients.
Our data will provide novel biological insight into the role and interplay of distinct hepatic type 1 and type 2 T cell
and NKT cell subsets in mediating viral clearance, protective immunity, tissue pathology or repair during a
hepatotropic virus infection in vivo.

Public health relevance
The role of functionally distinct hepatic T cell subsets in providing protective immunity from hepatotropic viruses, such as hepatitis C virus (HCV), or mediating liver pathology during inflammatory liver disease is poorly defined. Using a mouse model of an HCV-related virus we will investigate the functional properties and potential interplay of distinct type 1 and type 2 T cell and natural killer T (NKT) cell subsets during different stages of hepacivirus infection in vivo. Our results should reveal new concepts of hepatic T cell immunity with implications for the development of HCV vaccine strategies and new therapeutic options for liver disease.